Systematic Psychophysical Investigation of Visual Learning

Summary
The long-term goal of the proposed project is to elucidate the underlying mechanisms of visual perceptual
learning (VPL) for artificial and natural stimuli, which will be instrumental in developing rehabilitation programs
aimed at enhancing damaged or deteriorating vision. The specificity of VPL to the feature and location of the
trained visual stimulus is a fundamental characteristic of VPL. To investigate the specificity, one effective way is
to use an artificial stimulus such as a Gabor patch as the trained stimulus, as it has been widely used to
investigate basic visual processing. Simultaneously, to create an impactful rehabilitation program, the resulting
improvements must be generalized to untrained features and locations in visual stimuli encountered in everyday
life, including natural scenes (NS). However, it remains uncertain whether the same mechanisms underlie the
generalization and specificity in VPL for artificial and NS stimuli. In Specific Aim (SA) 1, we aim to examine
basic mechanism of the specificity using a Gabor patch. According to a prevailing theory, early visual processing
(e.g., 0 to 150ms after the stimulus onset) primarily involves input-level feedforward signals. In contrast, late
processing (e.g.,150-300ms after the stimulus onset) involves recurrent processing. To better understand the
mechanism of the specificity of VPL it is crucial to clarify whether early or late processing is involved. Additionally,
it remains unclear whether the specificity of VPL involves excitation on the trained feature and location or
inhibition on untrained features and locations. Therefore, we will test Hypothesis 1 (H1): Late processing (H1-
a) or early processing (H1-b) plays a role in the specificity of VPL, and H2: Excitatory signals (H2-a) or inhibitory
signals (H2-b) are involved in inducing the specificity of VPL. We will employ two methods. The backward
masking (BM) is used to disrupts and reveal roles of late processing. In preliminary results, BM applied to the
trained orientation eliminated the orientation specificity in VPL, supporting H1-a. A Rhythmic Synchronization
Orientation Decoding Change (RSDC) method is a novel method that examines at which band(s) of rhythmic
synchronization from EEG the decoding performances of trained and untrained features and locations change
after VPL training. Preliminary results suggest that trained orientation signals are enhanced at both trained and
untrained locations during early processing, while those at untrained locations are inhibited during late
processing, leading to the location specificity. In SA2, we will examine the specificity and generalizability of VPL
for NS. Our first step is to test H3: VPL for the dominant orientation in NS is specific (H3-a) or generalized (H3-
b) to other orientations. Preliminary results support H3-b. If true, we will further investigate the aspects in NS that
induce the generalization of VPL. Preliminary result suggests that higher-order statistics, involving correlations
between different orientation and spatial frequency channels derived from NS, play a role in the generalization
of VPL for NS. We further aim to test H1 and H2 for NS images, using both the BM and RSDC methods.

Public health relevance
Project Narrative In this proposal, by means of behavioral testing, we aim to clarify how vision is improved by visual training. The proposed investigations would lead to a significantly better understanding of visual and brain plasticity, which may lead to interventions to amblyopia, and other pathological or age-related visual declines.